BETA CAROTENE ACTION ON DECLINES IN LYMPHOCYTE SUBSETS OF WOMEN WITH CANCER

Local radiation causes significant declines in lymphocyte counts. The mechanism for this decline as well as the types of lymphocytes making up this decline are presently unknown. In animals, beta-carotene attenuates this decline. The purpose of the present study is to characterize the T cell subsets that are declining in response to local radiation as well as examine the effect of beta-carotene to block this effect. This study is double-blinded. Study continues with 6 out of the proposed 20 done. Data pending.